Integrated Data Visualization Core

PROJECT ABSTRACT – Component: Core C (Integrated Data Visualization Core)
The Southwest Center on Resilience for Climate change and Health (SCORCH) will bring together
transdisciplinary research groups to conduct solutions-oriented team-science projects responsive to the health
needs of arid lands communities adapting to climate change. The Integrated Data Visualization Core (IDVC)
supports the overall Center mission through the provision of data science, visualization, and management
expertise. The IDVC structure is organized around three services providing 1) data management, sharing, and
analyses support, congruent with scientific data management and stewardship best practices; 2) data
visualization; and 3) training and workshop opportunities to develop and enhance team member and partner
capacity to manage and visualize integrated health and climate data. Coordinating with the Administrative and
Community Engagement Cores, the expertise and technical support offered through the IDVC will enhance
institutional capacity to conduct climate change and health research tailored to the needs of Arid Lands
communities.